Social determinants of sleep and obesity: Disparities in African Americans

PROJECT SUMMARY/ABSTRACT
The proposed research aims to reduce obesity-related health disparities by promoting healthy lifestyle behav-
iors among African Americans (AAs), given the high disease burdens associated with low physical activity, in-
sufficient sleep, and obesity. To this end, the candidate will seek to understand how social contextual factors
impact sleep by using qualitative interviews and an existing quantitative data sets (K99). Knowledge gained
from the K99 phase will inform the adaptation and testing of an existing sleep intervention (MDACC IRB Proto-
col #2018-0568) (R00). During the K99 phase, the candidate will receive focused and intensive training involv-
ing workshops, courses, lectures, and directed readings from renowned experts in the fields of health dispari-
ties, sleep medicine, and obesity. Two studies will include: (Aim 1) conducting qualitative in-depth interviews to
elucidate social contextual influences on sleep, while soliciting feedback to adapt a sleep intervention among
obese, sedentary, and short-sleeping AA adults; and (Aim 2) empirically testing the associations between so-
cial contextual factors, sleep, physical activity, and body weight using data from an ongoing studies of AAs
(Project FAITH; American Cancer Society, RSG-17-158-01; PI: Dr. McNeill, mentor). Lastly, during the R00
phase will compile the knowledge gained in the K99 phase to adapt a sleep intervention and test its feasibility,
satisfaction, and preliminary efficacy in improving sleep, increasing physical activity, and decreasing sedentary
behavior among overweight/obese, sedentary, and sleep-deprived AA adults (Aim 3). The candidate is
uniquely positioned to complete the proposed research based on his past clinical experience in treating insom-
nia and his research on sleep and obesity among AAs. The sleep intervention is a promising and innovative
approach to optimizing psychological and physical wellness to reduce obesity and cancer-related health dis-
parities – a research priority at the National Institute on Minority Health and Health Disparities. Furthermore,
the proposed training plan will be critical in expediting the candidate’s transition to an independent investigator
with focused expertise in developing culturally informed interventions to reduce cancer health disparities
among AAs.

Public health relevance
NARRATIVE African American adults sleep less and obtain worse quality sleep compared to the national average, and emerging evidence links inadequate sleep with morbidity and mortality from chronic diseases such as diabetes, obesity, and cancer. To address this public health concern, the proposed research seeks to understand social contextual factors related to sleep and obesity by using a multi-method approach, and to use the knowledge gained to adapt a sleep intervention for overweight, sedentary, and chronically sleep-deprived African Ameri- can adults. The goal of the project is to understand how the social context impacts sleep and obesity to reduce cancer-related health disparities among African Americans.